Institutional Contact and Family Violence in an Era of Mass Incarceration

ABSTRACT
American children are exposed to violence at a shockingly high rate. Over one in eight have had
the maltreatment they experienced confirmed by the authorities, and at least one in four have
witnessed inter-parental violence. Although formal institutions such as social service providers,
child welfare, and law enforcement agencies are intended to protect families, these institutions
may be seen less as family protectors than as agents of surveillance, punishment, and family
separation—especially in vulnerable communities. The overall goal of this research is to
understand how contact with formal institutions shapes family violence experiences and
their consequences for children. It will also allow the principal investigator, Dr. Tasseli
McKay, the opportunity to build the measurement expertise, analytic skills, and methodological
tools needed to conduct impactful, long-term research on the implications of mass incarceration
for family violence. The project consists of five studies, combining primary qualitative
interviews and mobile surveys with youth and parents in contact with punitive
institutions (such as juvenile and criminal legal systems) and secondary analysis of
survey and administrative data. It will generate (1) Estimates of the bidirectional relationship
between institutional contact and childhood family violence exposure (Aim 1, K99 phase); (2)
New, validated measures of institutional contact that capture objective institutional contacts and
subjective experiences of institutional responsiveness (Aim 2, K99 phase); (3) A qualitative
assessment of how institutional contacts and institutional responsiveness inform family violence
disclosure decisions among affected family members (Aim 3, R00 phase); (4) Estimates of the
influence of institutional contact events and institutional responsiveness on help-seeking
intentions and service utilization (Aim 4, R00 phase); and (5) A quantitative assessment of the
respective roles of institutional contact events and institutional responsiveness in shaping the
relationship between childhood exposure to family violence and involvement in violence during
the transition to adulthood (Aim 5, R00 phase). The project will produce advances in
conceptualization, measurement, and analytic methods that lay a foundation for new research
on institutional contact as a social determinant of child health and well-being and help
inform sound public policy and public health intervention for the most common and
impactful forms of violence: those within the family.

Public health relevance
NARRATIVE Family violence imposes substantial and long-lasting burdens on children, particularly those in heavily policed and incarcerated communities. But little is known about how objective and subjective experiences of institutional contact in such communities may affect family violence incidence, disclosure, help-seeking, or consequences. The proposed project will advance the study of children’s exposure to family violence in the contemporary United States by collecting primary qualitative and survey data and applying inductive and latent variable methods for formative analysis. psychometric validation, and hypothesis testing.